Nuclear myotubularin and its role in muscle development and the pathogenesis of X-linked myotubular myopathy

X-linked myotubular myopathy (XLMTM) is a devastating childhood muscle disease characterized clinically by
severe weakness and early death and pathologically by small myofibers that contain disorganized organelles
and myonuclei with aberrant appearance and localization. XLMTM is caused by mutations in the MTM1 gene.
How MTM1 mutations cause these phenotypes is not well known, and this lack of knowledge presents a key
barrier for disease understanding and therapy development. Myotubularin (MTM1) encodes a 3-position
phosphoinositide phosphatase that in vitro localizes to the endosome and has role(s) in regulating endosomal
vesicular sorting. In exciting new data, we have discovered for the first time subpopulation(s) of MTM1 at the
nuclear envelope and within the nucleus. We also reveal that Mtm1 knockout mice have structurally abnormal
myonuclei, display an arrest in muscle development and abnormalities in the myogenic transcriptome, and
have altered genome organization and a shift in chromatin accessibility. Further, we show that expression of
MTM1 exclusively in the nucleus can rescue aspects of the knockout phenotype. Based on these data, and our
previous work, we hypothesize that MTM1 regulates nuclear architecture and regional chromatin modifications,
and thereby participates as a key modulator of myogenesis. We additionally hypothesize that a critical
consequence of MTM1 mutation is to alter genome topography and interrupt the normal progression of the
myogenic expression program, resulting in failure of muscle development and disruption of myofiber growth.
We will test these novel, conceptually innovative hypotheses using our mouse model of XLMTM in three specific
aims. Aim 1 will characterize the localization and interactome of nuclear MTM1, and determine how these
change with Mtm1 knockout. Aim 2 will define the alterations in nuclear structure, genome organization, and
myogenic transcription associated with MTM1 mutation. Aim 3 will test the impact of nuclear vs non-nuclear
MTM1 during muscle development using a series of AAV driven rescue constructs. These Aims utilize state-
of-the field experimental approaches, including 3D block face electron microscopy, in vivo miniTurboID, spatial
transcriptomics and single nucleus RNAseq, and a novel HiC approach (scHiCAR) for defining genome
architecture. Findings from this project will be highly significant as they will advance understanding of the role
of MTM1 in normal nuclear function and in the regulation of an understudied area of muscle development
(postnatal sequential progression of the myogenic transcriptional program). In addition, this study will improve
our knowledge of XLMTM pathogenesis by addressing a key fundamental unknown (i.e. the contribution of the
pathognomonic nuclear abnormalities to the disease process) and by providing new knowledge that will lay the
groundwork for therapy development. To ensure success of this project and enable its highest impact, we have
assembled a collaborative investigator team expert in XLMTM and the key experimental approaches.

Public health relevance
Mutations in myotubularin (MTM1) result in a devastating childhood muscle disorder that is currently without treatment. There is incomplete understanding of the normal role(s) of MTM1 in muscle and why mutations cause alterations in the development, structure, and function of muscle. The goals of this proposal are to define normal MTM1 function(s) and to understand the reasons why loss of MTM1 results in muscle disease, goals which will be achieved through the study of nuclear MTM1 and the use of novel mouse models.